DATABASE TO MANAGE ELECTRONIC NIH GUIDE FOR GRANTS &CONTRACTS

This computer-only protocol proposes to continue to maintain and develop both the database and the programs that provide access to the electronic NIH-guide for grants and contracts. The investigator proposes to improve the searching tools for the DB to provide improved retrieval of items of interest to the researcher and to develop improved indexing tools, so that researchers are alerted to information of interest.